Influences of Housing on Maternal and Infant Health: 30-year Follow-up of a Randomized Trial

PROJECT SUMMARY/ABSTRACT
Addressing maternal and infant health disparities is an urgent public health concern with profound implications
for health equity across the life course. Causes of disparities in maternal morbidity and birth outcomes are
multifactorial and arise from an accumulation of short- and long-term environmental, economic, social,
behavioral, and biological processes that unfold across the life course. To understand and ultimately address
pregnancy disparities, research needs to move beyond cross-sectional designs at one point in life, to examine
upstream, place-based, and macrostructural determinants of health that occur much earlier in life, using
rigorous designs. Neighborhood context is a particularly important macrostructural, distal exposure, which is
influenced by residential segregation, but can be altered through housing policy. The proposed project aims to
understand the impact of housing policy on neighborhood context and infant and maternal outcomes in the
U.S. To study this critical public health problem, we will leverage data from the Moving to Opportunity (MTO)
Study. MTO started as a randomized trial of 16,000 individuals (adults and their children) in 4,600 low-income
families, living in public housing at baseline, in five U.S. cities. Volunteer families were randomized beginning
in 1994 to receive one of three treatments: (1) a housing voucher that subsidized rent in apartments located in
low-poverty neighborhoods (<10% poverty) plus housing counseling; (2) a housing voucher subsidizing rent in
any neighborhood; or (3) an in-place control group that received no voucher but remained eligible for public
housing. The original MTO study ran from 1994-2010. We propose to link the MTO study participants to
population-based administrative data to extend the study for an additional 15 years until 2024. Linkage with
universal data will enable us to analyze the long-term effects of this experiment on household heads, their
(now adult) children, and their infant grandchildren. We have four specific aims: (1) Test if MTO treatment
improves neighborhood quality (neighborhood opportunity) in 2024; (2) Test if MTO treatment affects maternal
morbidity (e.g., hypertensive disorders of pregnancy, gestational diabetes, obesity); adverse birth events (low
birthweight, preterm birth); or fertility (short birth interval, number of births) by 2024; (3) Identify subgroups that
are more or less likely to benefit from the MTO housing voucher experiment, i.e., test heterogeneity of MTO
effects on fertility, maternal morbidity and adverse birth outcomes by baseline demographic factors and their
combinations (effect modification); and (4) Calculate the number of adverse maternal and infant related events
avoided, and how the racial/ethnic health gap would be narrower, at the population level, if voucher-based
housing policy were broadly implemented to promote opportunity moves (simulation). This rigorous, long-term
population health research project aims to achieve health equity across multiple generations of families, by
improving housing and neighborhood contexts early in life.

Public health relevance
NARRATIVE Addressing maternal and infant health disparities is an urgent public health concern with profound implications for health equity across the life course. The proposed research leverages data from a large federal housing policy experiment begun in 1994 to test whether housing policy improved maternal and infant health for girls and women across 30 years. The overarching goal is to test if housing policy can disrupt segregation and reduce pregnancy disparities by enabling minoritized girls and women to move into higher quality neighborhoods.